A brain multi-omic approach to identify key molecular drivers of neuropsychiatric

Approximately 65% of individuals with mild cognitive impairment (MCI), Alzheimer's disease (AD), or
AD related dementias (ADRD) experience neuropsychiatric symptoms (NPS). These debilitating symptoms
include depression, anxiety, apathy, delusions, hallucinations, agitation, sleep disturbances and are associated
with faster disease progression, greater functional impairment, higher caregiver burden, and earlier
institutionalization. Current treatments for NPS in MCI/dementia have limited efficacy but high rates of adverse
side effects, including higher mortality. Therefore, safe and effective treatments for NPS are urgently needed.
However, we have limited insights into molecular mechanisms of NPS in MCI/dementia to nominate
therapeutic targets. To address this knowledge gap, we aim to elucidate the genetic and molecular
mechanisms underlying NPS in MCI/dementia using two complementary but independent approaches. Our
proposed plan was to use tandem mass tagged-based proteomics; however, since the submission of the
proposal and the awarding of funding, the equipment at the Emory Core Proteomics facility is now committed
to many new NIH-funded projects. The consequence of these newly awarded projects is reduced capacity of
the Core to complete our proposed aims at the proposed timeline. This supplement will support the timely
throughput of the whole brain proteomics by proposing to lease-to-own a liquid chromatography coupled to a
mass spectrometer to complete the proposed specific aims following the proposed timeline.

Public health relevance
Approximately 65% of Alzheimer's disease (AD) patients experience neuropsychiatric symptoms (NPS), which are associated with accelerated disease progression, greater functional impairment, higher caregiver burden, and earlier institutionalization. This supplement will support deep proteomic sequencing of brain samples donated by participants with longitudinal NPS assessments to facilitate the identification of molecular mechanisms underlying NPS.